Peer-led Implementation of TB-HIV Education and Adherence Counseling in Uganda

PROJECT SUMMARY
Among the ~2.5 million persons who develop incident tuberculosis (TB) in sub-Saharan Africa annually, about
one in five does not complete treatment, even though highly effective treatments for TB and concurrent HIV are
now widely available. This contributes significantly to the high TB mortality worldwide, especially among persons
living with HIV. Clinical and public health guidelines universally recommend TB education and counseling (TB-
EC) to improve adherence to and outcomes of TB treatment and antiretroviral therapy (ART), but many barriers
to delivery exist. There is growing community interest in adapting peer-led strategies from the HIV field to improve
provision of TB-EC and outcomes of TB and HIV. We recently developed and implemented a multi-component
peer-navigation strategy for delivery of TB-EC among persons with TB with and without HIV in Uganda, including
(1) task-shifting of TB-EC to peers with TB; (2) restructuring of clinic workflows; (3) a TB-EC checklist; (4)
individualized adherence planning; and (5) behavior-change messaging. In a preliminary evaluation, we found
that the adapted TB-EC strategy was feasible and acceptable, and improved both TB literacy and treatment
outcomes. We now propose a 16-site, cluster-randomized, hybrid Type 2 effectiveness-implementation trial to
evaluate the impact of peer-navigation on TB/TB-HIV treatment adherence and clinical outcomes among new
PWTB with and without HIV in Uganda. We will conduct these studies through the Uganda TB Implementation
Research Consortium (U-TIRC), an academic-public health partnership hosted at the Walimu non-governmental
organization and involving Makerere University, the Uganda National TB Program (NTP), New York University,
and Yale University. Our primary effectiveness outcomes include TB treatment completion and ART retention at
one year. Our primary implementation outcomes include TB treatment and ART initiation, adherence, and
persistence. We will conduct rigorous mediation analyses to test our hypotheses about the social and behavioral
mechanisms through which peer navigation strategy was designed to influence client outcomes. We will nest
convergent mixed-methods studies of implementation fidelity and context to understand provider and health
system influences. Our overall hypothesis is that peer navigation will improve TB/TB-HIV treatment adherence
and clinical outcomes compared to standard TB-EC by addressing individual and health-system barriers to TB
treatment and ART. These studies address several NIH research priorities, including overcoming barriers to
implementing evidence-based interventions for TB-HIV and improving medication adherence. We expect that
our rigorous design and implementation plans will provide high-quality data on the effectiveness and
implementation of a novel peer-navigation strategy to promote TB treatment and ART adherence. We will
disseminate our findings to participants, the Uganda National TB Program, and the global TB and HIV
communities to inform how TB-EC is offered to persons with TB/TB-HIV. If successful, our study will lead to
future work evaluating the impact, sustainability, and cost-effectiveness of the peer-navigation strategy at scale.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is the leading infectious cause of death worldwide, including among persons living with HIV. Peers with a history of TB or TB-HIV offer an untapped source of knowledge and social support to help persons with TB and TB-HIV better adhere to HIV and/or TB medications. This cluster-randomized trial in Uganda will evaluate the effectiveness and implementation of a novel, peer-led TB education and counseling strategy to improve outcomes among persons with TB with and without HIV and determine if and how social and behavioral factors like knowledge, social support, stigma, and self-confidence affect treatment outcomes.